Determining the spindle dynamics regulatory network with an integrated approach

DESCRIPTION (provided by applicant): Tight regulation of the spindle microtubule (MT) dynamics is vital for the success and fidelity of mitosis, but the mechanism for regulating spindle MT dynamics remains unknown. Without this knowledge, a complete understanding of spindle regulation during mitosis is impossible. In recent years, a number of MT regulatory proteins have been identified, but little is known of how they interact with each other to collectively manipulate spindle MT dynamics. The first endeavor along this direction is the recent identification of a network of five regulatory proteins (KLP59C, KLP67A, Mast, EB1 and Msps) that governs kinetochore MT (kMT) plus-end dynamics during metaphase. This network utilizes a complex balance between MT polymerases and depolymerases (instead of polymerases alone) to induce net polymerization at kMT plus-ends, which counteracts constant depolymerization at minus-ends to maintain the metaphase kMTs in a steady state. The long-term goal is to elucidate the molecular events that drive the assembly and function of the mitotic spindle. The objective of this application is to determine how the actions of only a handful of MT regulatory proteins give rise to the broad range of dynamics at spindle MT plus-ends from prometaphase through anaphase. The central hypothesis is: the regulatory networks controlling spindle MT dynamics at other mitotic stages can be attained by shifting the balance among the components of the metaphase network. Guided by strong preliminary data, this hypothesis will be tested through the pursuit of three specific aims: (1) Determine the changes to the kMT regulatory network that transform the plus-end dynamics from net polymerization (metaphase) to net depolymerization (anaphase A). (2) Determine the kMT regulatory network that generates the plus-end dynamics driving chromosome congression during prometaphase. (3) Determine the regulatory networks governing non-kinetochore MT plus-end dynamics to establish/maintain a bipolar spindle during pre- anaphase and to promote spindle elongation during anaphase B. These aims will be achieved using complementary computer simulation, a custom-developed automatic image tracking method, live cell imaging and RNAi-based protein knockdowns. By bridging hypothesized molecular interactions with cellular-scale experimental observables quantitatively and rigorously, simulations allow us to discriminate alternative molecular mechanisms that experiments alone cannot due to lack of necessary spatial and temporal resolution. The innovation of this plan stems from both the novelty of its hypotheses and the broad and unique array of tools it wields to test them. The proposed research is significant because it will provide a systems-level understanding of an essential module of the spindle machinery, which will fill a severe gap in the current knowledge of mitosis. Moreover, the knowledge thus gained will deepen the understanding of the mechanisms of aneuploidy--the underlying cause of many forms of cancers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed studies are of an important and under-investigated area of mitosis that has potential applicability to understanding the mechanisms of aneuploidy--the underlying cause of many forms of cancers. The proposed research has relevance to public health, because the fundamental mechanisms to be investigated are expected to be conserved across the phyla. Thus, the findings are ultimately expected to be applicable to the health of human beings. The proposed studies are of an important and under-investigated area of mitosis that has potential applicability to understanding the mechanisms of aneuploidy--the underlying cause of many forms of cancers. The proposed research has relevance to public health, because the fundamental mechanisms to be investigated are expected to be conserved across the phyla. Thus, the findings are ultimately expected to be applicable to the health of human beings. __SpecificAimsTextDelimiter__ PI: Ma, Ao A. SPECIFIC AIMS Tight regulation of the spindle microtubule (MT) dynamics is vital for the success and fidelity of mitosis. MTs within the central spindle can be categorized into two functionally distinct groups: (1) kinetochore associated MTs (kMTs) that control chromosome congression/segregation, and (2) non-kinetochore MTs (nkMTs) that drive spindle morphogenesis and determine spindle length. Using a combination of computational and cell biological approaches, we identified a plausible network of regulatory proteins that governs kMT plus-end dynamics during metaphase [2] (Fig. 1). This network utilizes a complex balance between MT polymerases and depolymerases (instead of polymerases alone) to induce net polymerization at kMT plus-ends, which counteracts constant depolymerization at minus-ends to maintain the metaphase kMTs in a steady state. The general mechanism for regulating spindle MT dynamics at other mitotic stages still remains unknown. Without this knowledge, a complete understanding of spindle regulation during mitosis is impossible. Our long-term goal is to elucidate the molecular events that drive the assembly and function of the mitotic spindle. The objective of this application is to determine how the actions of only a handful of MT regulatory proteins produce Fig. 1: The metaphase kMT plus-end regulatory network: (a) this network consists of a minimum set of regulatory proteins (including two MT depolymerases (KLP67A, KLP59C), two MT polymerases (Mast, EB1), and Msps) and the functional interactions among them, (b) Msps stimulates the dynamicity of a MT end and prepares it for regulation by other proteins, (c) Mast inhibits KLP59C at kinetochores, (d) Mast and EB1 maintain a tight functional inter-relationship. Red line: enhancing interaction; black line: inhibitory interaction. the broad range of dynamics at spindle MT plus-ends from prometaphase through anaphase. Based on preliminary and published findings, our central hypothesis is: the regulatory networks controlling spindle MT dynamics at other mitotic stages can be attained by shifting the balance among the components of the metaphase network. This hypothesis will be tested through the pursuit of three specific aims. Specific aim 1: What are the changes to the kMT regulatory network that transform the plus-end dynamics from net polymerization (metaphase) to net depolymerization (anaphase A)? Working hypotheses: (1) Activation/up-regulation of MT depolymerases tilts the balance of kMT plus-end dynamics towards net depolymerization. (2) Katanin effects prompt anaphase transition by updating the regulatory proteins assembled at kMT plus-ends via its MT severing activity. Specific aim 2: What is the kMT regulatory network that generates the plus-end dynamics driving chromosome congression during prometaphase? Strikingly, prometaphase kMTs behave differently depending on if they are linked to leading (closer to the spindle equator) or trailing kinetochores: leading kMTs shrink while trailing kMTs elongate. Alternative hypotheses: (1) Regulatory networks at both the leading and trailing kinetochores have the same composition as that of metaphase, but the plus-end dynamics differ because the depolymerization activity of KLP67A [3] increases with MT length. (2) Regulatory networks at both leading and trailing kinetochores favor MT polymerization, but the leading kMTs shorten, due to enhanced minus-end depolymerization, after being pushed into the spindle pole by outnumbering trailing kMTs. Specific aim 3: What is the regulatory network governing nkMT plus-end dynamics pre- and post- anaphase? Working hypotheses: (1) Before anaphase B, Mast, EB1, KLP59C and KLP67A act independently at nkMT plus-ends to establish/maintain a bipolar spindle. (2) MT depolymerases (e.g. KLP67A) are inhibited/down-regulated at nkMT plus-ends, at anaphase transition, to stimulate spindle elongation. These aims will be achieved using complementary computer simulation, a custom-developed automatic image tracking method, live cell imaging and RNAi-based protein knockdowns. By bridging hypothesized molecular interactions with cellular-scale experimental observables quantitatively and rigorously, simulations allow us to discriminate alternative molecular mechanisms that experiments alone cannot due to lack of necessary spatial and temporal resolution. Our general strategy is to first test all the alternative models in silico to devise the critical experiments for discriminating between them. Subsequent comparison of simulation- predicted MT dynamics with in vivo experimental results will allow us to confirm or refute specific aspects of our hypotheses and, if necessary, revise our assumptions. The innovation of this plan stems from both the novelty of its hypotheses and the broad and unique array of tools it wields to test them. Given our expertise and strong preliminary data we feel uniquely positioned to accomplish our aims. Finally, one important positive impact of the proposed research is that the knowledge thus gained will deepen our understanding of the mechanisms of aneuploidy--the underlying cause of many forms of cancers.